Leveraging the biphasic life cycle of a non-vertebrate chordate to investigate developmental transitions and phenotypic plasticity

PROJECT SUMMARY/ABSTRACT
Our laboratory’s research on Ciona is centered on uncovering fundamental but currently unknown
mechanisms regulating important cellular processes like fusion, survival, quiescence, and growth.
Tunicates like Ciona are the invertebrates most closely related to vertebrates, yet possess a biphasic
life cycle. During metamorphosis, a mass wave of cell death and resorption eliminates most
differentiated larval cells while sparing set-aside undifferentiated adult progenitor cells that go on to
form the majority of adult cell types and structures.
In many cases, these adult cell types are distinct from their larval counterparts. For instance, while
larval muscles are mononucleated, like that of other non-vertebrate deuterostomes, their adult
muscles are multinucleated and form through myoblast fusion through the fusogenic factor Myomaker,
which is shared only with vertebrates. We are particularly interested in understanding how these two
very distinct muscle types (larval mononucleated vs. adult multinucleated) are made, and we hope to
leverage this unique dichotomy to identify potentially conserved, but as-of-yet unidentified effectors of
cell-cell fusion acting in the same Myomaker-dependent pathway. Our goal in the next 5 years for this
specific project is to identify additional genes regulating cell-cell fusion and further our understanding,
currently quite poor, of Myomaker structure-function at a subcellular level.
Despite the heterochrony and phenotypic plasticity of larval vs. adult cells, and the complete
remodeling of body plans and tissues, the larval and adult compartments are contiguous and
simultaneously patterned during embryonic development. This peculiar arrangement offers a unique
opportunity to study how discrete stem cell compartments can be set aside and protected for later
developmental potential in spite of the differentiation and cell death around them. Our research has
recently pinpointed the FGF/MAPK pathway as a key regulator of the fate choice between larval vs.
adult cell. In the “Neck”, a compartment of the larval central nervous system, sustained FGF/MAPK
signaling carves out a niche of adult-specific stem cells that survive metamorphosis and go on to
proliferate and differentiate in the adult phase. By perturbing FGF/MAPK signaling, we can instead
convert these cells into larval neurons, which are the fated to be eliminated during metamorphosis. In
the next 5 years, our goal is to identify the pathways and molecular components downstream of
FGF/MAPK that effect this dramatic death-or-survival switch.

Public health relevance
Project narrative Human development and survival depends greatly on how and when individual cells decide to proliferate, lay dormant, or carry out specialized functions like the formation of muscle fibers through cell-cell fusion. We will use the small, transparent embryos of Ciona, one of the invertebrates most closely related to humans, to better understand which genes are activated to allow certain cells to survive the remarkable remodeling of the animal during metamorphosis from the larval to the adult phase. We will also study the process of cell-cell fusion in Ciona, which is shared with humans and other vertebrates.